Research Methods Core

The primary aim of the Research Methods Core will be to complete the development and feasibility testing of the three technologies under the Technology Development Unit. In addition, a Measurement Unit will investigate measurement and analytic tools for two specific metrics that have repeatedly been identified as needs: adherence to internet treatments, and methods of measuring cost and cost-effectiveness.